Building on Needle Exchange to Optimize HIV Prevention/Treatment

PROJECT SUMMARY
Latinos are among the most heavily impacted communities by the COVID-19 pandemic in the US, with more
than 3 times higher rate than non-Hispanic whites. To address this disparity, this team of investigators and
community partners has established a multi-pronged approach that leverages the skill set of trusted
bilingual/bicultural peer navigators (or promotoras) to address social determinants of health (SDOH) that create
barriers to testing (such as lack of insurance, immigration status, stigmatization or loss of job/income), and to
expand access to free COVID-19 testing in community settings. Our preliminary findings show that leveraging
the promotora model for timely delivery of results (within 48 hours), paired with rapid linkage of COVID-19
positive patients to critical services (including clinical follow-up, food delivery, cash assistance, and/or isolation
hotel), and referral of contacts for testing, increased acceptability and uptake of COVID-19 testing in a heavily
impacted Latino community. The overall goal of this Phase I Testing Research Project called Juntos (Together)
is to work closely with our community partners to systematically evaluate and refine current COVID-19 testing
strategies, and to implement and evaluate innovative customized strategies to rapidly increase reach, access,
acceptance, uptake, and sustainment of FDA-authorized/approved diagnostics (especially viral tests) for this
highly vulnerable and health care marginalized community. Leveraging community partnerships and prior
experience implementing an HIV testing campaign, we will develop and evaluate a customized Juntos COVID-
19 testing campaign to address specific common concerns in the Latino community and link users to existing
Johns Hopkins COVID-19 community testing sites and to new options, including home-based and/or self-
testing kits and rapid tests (Aim 1). To assess the overall impact of the Juntos COVID-19 Testing Project, we
will rely on the latest in causal inference methods for evaluating population-level health interventions and
implement a synthetic control analysis to compare testing uptake and positivity rate among Latinos in Baltimore
City (intervention site) as compared to control zip codes across Maryland. (Aim 2). Finally, informed by
Consolidated Framework for Implementation Research (CFIR) and RE-AIM framework, we will assess the
implementation determinants, mechanisms, and outcomes of existing and novel Juntos testing interventions to
inform future broad-scale implementation (Aim 3). We have assembled a multi-disciplinary team with
methodological expertise in implementation science, community-based research, and laboratory medicine, and
have a mature and long-standing collaboration with our partners at Esperanza Center, Casa de Maryland, the
Mayor's Office of Immigrant Affairs, and religious leaders. Our team is enthusiastic to propose this
implementation study to enhance access to testing for the Latino community, and will actively coordinate and
share data and protocols with other grantees, the CDCC, and other research supported by the RADx-UP
program.

Public health relevance
PROJECT NARRATIVE Latinos are among the most heavily impacted communities by the COVID-19 pandemic. There is an urgent need to promote COVID-19 testing and reduce disparities in the Latino community. In this grant, we propose to work closely with our community partners to implement and evaluate a COVID-19 testing strategy that is responsive to the needs of the Latino community, and includes testing in the community, a bilingual COVID-19 hotline, a website that connects people to reliable information and testing options, and the support of peer health navigators (or promotoras) to facilitate access to tests, results, and linkage to other services.